Genetic and cellular analysis of glial development and function in vertebrates

Glia are non-neuronal cells with diverse functions that range from forming the myelin sheath to defending the
brain against infection. A major goal of our research is to use the powerful experimental advantages of
zebrafish to discover new genes that are essential for the development and function of two classes of glia in
the CNS, oligodendrocytes and microglia.
Oligodendrocytes form myelin on axons in the CNS. After an oligodendrocyte begins to myelinate axons, it has
only a short developmental window (or “critical period”) to extend new myelinating processes. Using genetic
and cellular approaches in zebrafish, we have identified a number of positive and negative regulators of
myelination. One of our goals is to determine how these factors control myelination during development,
neural plasticity, and remyelination. In addition, we will investigate the molecular basis of the critical period.
Microglia are highly motile, phagocytic glial cells in the CNS that destroy pathogens and clear debris such as
apoptotic cells and damaged axons. Despite the importance of microglia in CNS health and disease, many
critical questions remain to be addressed about these cells. We have conducted zebrafish mutational screens
to discover essential microglial genes, and we are characterizing their functions using in vivo imaging and
other approaches.
The mechanistic insight gained from these studies will advance our fundamental understanding of the central
nervous system, illuminate the pathways that are disrupted in diseases of the brain, and suggest avenues
toward therapies for neurological disorders.

Public health relevance
Oligodendrocytes and microglia are two types of glial cells with critical functions in the brain. Despite their important roles in health and disease, many questions remain unanswered about the genetic mechanisms that control the development and function of these cells. The goal of this project is to use the powerful genetic and cellular approaches in the zebrafish model system to discover new genes with essential functions in oligodendrocytes and microglia. The mechanistic insight gained from these studies will advance our fundamental understanding of the central nervous system, illuminate the pathways that are disrupted in diseases of the brain, and suggest avenues toward therapies for neurological disorders.